Development of vaccines to bacterial diseases found especially in children

Introduction to projects of the Laboratory[unreadable] [unreadable] Members of the LDMI pioneered the development of a new generation of vaccines in which capsular polysaccharides are chemically conjugated to highly immunogenic but nonspecific proteins. These conjugate vaccines, which confer T-cell dependence and booster responses to polysaccharide antigens, have been singularly successful, as exemplified by the H. influenzae type b conjugate vaccine. H. influenzae type b meningitis (the most common cause of acquired mental retardation) has been virtually eliminated wherever the vaccine has been used. The methods developed for the vaccine have now yielded conjugate vaccines against pneumococci, Salmonella typhi, nontyphoidal Salmonella, Shigella, and Vibrio cholerae. The Vi capsular polysaccharide conjugate was over 90 percent effective against typhoid fever in two- to five-year-olds. Based on a level of anti-Vi that the study found to be protective, clinical trials are underway to evaluate the immunogenicity of Vi-rEPA, which is being administered concurrently with DTP during the primary injection of infants.[unreadable] By producing a nontoxic mutant Shigella toxin and conjugating it to the capsular polysaccharide of E. coli O157, LDMI researchers produced an experimental vaccine against this structure, which causes the often fatal hemolytic uremic syndrome, especially in small children. The investigational vaccine has proven to be safe and immunogenic in infants, and clinical trials for efficacy are now being planned.[unreadable] A conjugate vaccine against Staphylococcus aureus, the cause of many hospital-acquired infections, has been tested successfully in hemodialysis patients, who are at increased risk of infection by this pathogen.[unreadable] In an effort to produce an anthrax vaccine with fewer side effects than those associated with the currently available vaccine, a recombinant protein antigen vaccine against Bacillus anthracis, produced on an industrial scale in collaboration with researchers at the NIDDK, has been shown to elicit levels of neutralizing antibody in mice comparable to AVA and is now in a Phase 1 trial.[unreadable] Work is in progress to produce a conjugate vaccine against Borrelia burgdorferi, the causative agent of Lyme disease.[unreadable] Lastly, the LDMI has coordinated long-term clinical studies in Denmark and Iceland to complement their short-term study what all show there are no autoimmune diseases that following systemic infection with Group B Neisseria meningitides (GBM). Production of a clinical lot of our GBM polysaccharide conjugate is underway.